The Postischemia Inflammatory Syndrome in the Aged Kidney

DESCRIPTION (provided by applicant): Chronic kidney disease (CKD), end stage renal disease and their complications are a public health problem of epidemic proportions. CKD afflicts more individuals over 65 years old than diabetes or congestive heart failure, approximately 40% of older patients. Postulated explanations for increased susceptibility to renal failure with increasing age include the high frequency of diabetes and ischemia. Our preliminary data support the clinically relevant hypothesis that ischemia accelerates the progression of nephropathy in the aged kidney by activating proinflammatory pathways in tubular epithelia ultimately resulting in apoptotic cell death, fibrosis and renal failure. Furthermore, we have demonstrated critical roles for the proinflammatory receptors intercellular adhesion molecule-1 (ICAM-1) and lectin-like oxidized low density lipoprotein receptor (LOX-1) in this postischemia inflammatory syndrome. We now postulate that both systemic, particularly interleukins (interleukin)-1 and -6, and intrarenal (angiotensin II and p38 mitogen activated protein kinase) mediators regulate ICAM-1 and LOX-1 and therefore inflammation and function in the aged, diabetic postischemia kidney. To directly test our hypotheses, we propose the following specific aims: (To determine the mechanisms by which metabolic derangements and hypoxia result in tubular epithelial activation to a proinflammatory phenotype. We have demonstrated activation of tubular epithelia to a proinflammatory state with upregulation of ICAM-1 and LOX-1 both in vivo in diabetes/obesity and in vitro in cultured renal tubular epithelial cells exposed to proinflammatory lipids. Using this cell culture model to define the mechanisms of ICAM-1 and LOX-1 regulation and alteration of function will allow control of more factors and the use of specific blockers to thoroughly dissect the mechanisms of inflammation and injury. We will determine the key mediators of induction of ICAM-1 and LOX-1 in these cells and evaluate inhibitors for potential use in vivo. (To define the mechanisms of renal inflammation, particularly tubular induction of ICAM-1 and LOX-1, in the postischemia inflammatory syndrome in the aged ZS rat kidney. We hypothesize that systemic interleukin (IL)-1, IL-6, as early regulators; and intrarenal p38 mitogen activated protein kinase (MAPK) and angiotensin II, as amplifiers, are critical in ICAM-1 and LOX-1 expression in renal tubules in chronic kidney disease. Furthermore, we propose that blocking inflammation with mycophenolate mofetil or specific inhibition of ICAM-1, IL-1, angiotensin II or p38 MAPK will ameliorate renal injury in the postischemia inflammatory syndrome in the aging, diabetic kidney. Finally, we will evaluate tubular cell transplantation as an innovative therapy for renal failure. The proposed studies examine the novel hypothesis that age-related renal disease results (at least in part) from inflammation, including that mediated by ICAM-1 and LOX-1; that IL-1, IL-6, p38 MAPK and angiotensin II are critical in the induction of ICAM-1 and LOX-1 and that specific blockers of inflammation will result in improved function in the postischemia inflammatory syndrome in the aged kidney.

Public health relevance
PUBLIC HEALTH RELEVANCE: Chronic kidney disease (CKD) in those older than 60 years has increased markedly to approximately 28% of the population. In the US, more people are afflicted with CKD than either diabetes or congestive heart failure. Nearly one-half of patient beginning dialysis for CKD were e65 yo. We propose to study inflammatory and vascular injury and cell death and the effects of potential therapies in a model of CKD. PROJECT NARRATIVE Chronic kidney disease (CKD) in those older than 60 years has increased markedly to approximately 28% of the population. In the US, more people are afflicted with CKD than either diabetes or congestive heart failure. Nearly one-half of patient beginning dialysis for CKD were e65 yo. We propose to study inflammatory and vascular injury and cell death and the effects of potential therapies in a model of CKD. __SpecificAimsTextDelimiter__ Mechanisms by which age may exacerbate abnormal responses in the diabetic kidney and worsen chronic injury. THE POSTISCHEMIA INFLAMMATORY SYNDROME IN THE AGED KIDNEY (1-7) (1) (8-12) SPECIFIC AIMS: Chronic kidney disease (CKD) in those older than 60 years has increased markedly to nearly 39% of the population. In the US, more people are afflicted with CKD than either diabetes or heart failure (13). Age and diabetes are both risks for developing acute kidney injury (AKI) (14). A 10 year increase in age confers a 63% increase in risk of AKI (15). AKI, in turn, raises the odds of CKD and end stage renal disease (ESRD) in older patients(16). Nearly one-half of new ESRD patients in 2000 were e65 yo(13). The postulated explanations for increased susceptibility to renal failure with increasing age include microvascular attenuation, nephrotoxic medications, and systemic disease such as diabetes (17). Preliminary data support the clinically relevant hypothesis that ischemia accelerates the progression of nephropathy in the aged kidney by activating pro- inflammatory pathways in tubular epithelia ultimately resulting in apoptotic cell death, fibrosis and loss of function. We have demonstrated increases in the pro-inflammatory receptor for oxidatively modified low density lipoprotein (LDL), LOX-1, and the adhesion receptor intercellular adhesion molecule-1 (ICAM-1) in the diabetic and postischemia kidney. We hypothesize that this leads to a cycle of inflammation and then the rapid decline of renal function in the postischemia inflammatory syndrome. LOX-1 (18-20) and ICAM-1 (21-23) are also increased with aging. We propose that both systemic [interleukin (IL)-1β and IL-6] and intrarenal [angiotensin II, p38 mitogen activated protein kinase (MAPK)] inflammatory mediators are critical in ICAM-1 and LOX-1 induction in tubu- lar epithelia and loss of renal func- tion. To directly test these hypoth- eses, we propose the following specific aims: Older age, diabetes and/or chronic kidney disease (CKD) increase the risk of acute kidney injury (AKI). Particularly in older patients, AKI can exacerbate CKD [35-40]. Specific Aim 1: To determine the mechanisms by which metabolic derangements and hypoxia result in tubular epithelial activation to a proinflammatory phenotype. We have demonstrated a proinflammatory transformation of tubular cells in diabetes (24) and postischemia (25). We will define the mechanisms of activation of ICAM-1 and LOX-1 in cultured renal tubular epithelial cells exposed to proinflammatory lipids, elevated glucose and hypoxia. We will examine (a) IL-1β, IL-6 and migration inhibitory factor (MIF), as these lie at the head of the inflammatory cascade; (b) angiotensin II, p38 MAPK and NFkB, as these are key regulators/amplifiers of the response. We hypothesize that these mediators are central in the induction of ICAM-1 and LOX-1 in tubular epithelial. We will define the effect of these mediators on leukocyte-epithelial adhesion, cytokine secretion and cell death. These studies will define, in detail, the mechanisms of ICAM-1 and LOX-1 induction in a system in which many factors can be controlled and potential therapies evaluated. Specific Aim 2: To define the mechanisms of renal inflammation, particularly tubular induction of ICAM- 1 and LOX-1, in the postischemia inflammatory syndrome in the aged kidney. We hypothesize that systemic (such as IL-1 and IL-6) and intrarenal (p38MAPK and angiotensin II) mediators are critical in renal dysfunction in the postischemia inflammatory syndrome in the aged ZS rat kidney. We will examine potential therapeutic effects of transplanting tubular cells (which report NFkB activation via urinary marler). To both define mechanism and potential therapies, we will determine the effect of specific blocking agents of systemic and intrarenal activation of ICAM-1 and LOX-1 on renal fibrosis, proteinuria and function. The proposed studies examine the novel hypothesis that age related renal disease results (at least in part) from inflammation, including that mediated by ICAM-1 and LOX-1, and will employ the powerful techniques of intravital microscopy. An mechanistic understanding of CKD progression with age and inflammation and apoptosis in this unique model of CKD due to diabetes/ischemia will allow testing of innovative therapies.